Roles of Autophagy in Microglial Senescence and Parkinsons Disease

Project Summary
Parkinson’s disease (PD) is the most common age-dependent movement disorder; however, it remains
mysterious how aging predisposes the brain to PD. As the body ages, senescent cells become accumulated in
multiple organs, including the brain. Recent evidence showed that removal of senescent glial cells, including
microglia, alleviates disease phenotypes in animal models of Alzheimer’s disease (AD) and PD. Microglia are
brain-specific macrophages that continuously survey the brain to maintain brain homeostasis. Senescent
microglia may lose their neuroprotective functions and secret senescence-associated secretory phenotype
(SASP), leading to chronic inflammation. Therefore, there is a critical need to examine the impact of senescent
microglia on human PD. Our preliminary data with single-nucleus RNA sequencing (snRNA-seq) technology
revealed that a subset of microglia expresses more senescence-related genes in human PD brain. The long-
term objectives of this research are to elucidate whether and how microglia become senescent in PD and to
characterize the molecular signature of senescent microglia for finding out therapeutic targets. In Aim1, we will
determine whether senescent microglia become accumulated in PD and establish the relationship between
autophagic flux and microglial senescence using human PD postmortem brain. Autophagy is a cellular
degradation pathway responsible for removing damaged cellular organelles, protein aggregates, and invading
foreign substances. Autophagy plays a role in extending healthy lifespan and preventing cellular senescence in
animal models. Our preliminary data highlights that autophagy prevents microglial senescence in mouse. In
Aim2, we will characterize the transcriptomic and proteomic signatures of senescent microglia in human PD
postmortem brain by employing snRNA-seq and spatial omics technologies. In Aim 3, we will utilize human
microglia from induced pluripotent stem cells (iPSC) to study the roles of autophagy in microglial senescence.
We will apply RNA-seq and LC-MS/MS to elucidate the transcriptomic profile and SASP of senescent microglia,
respectively. Lastly, we will determine the effect of SASP from senescent microglia on the survival of human
dopaminergic neurons. Successful completion of this project will 1) provide evidence for microglial senescence
in human PD brain, 2) characterize the molecular signature of senescent microglia, and 3) provide insight into
the mechanism of how autophagy regulates microglial senescence and how senescent microglia affect
dopaminergic neurons.

Public health relevance
Project Narrative The greatest risk factor for developing Parkinson’s disease, outweighing all others, is age. However, it is unclear how aging predisposes the brain to PD. This project studies the mechanism of how microglia become senescent, characterizes the senescent microglia, and determines the impact of senescent microglia on dopaminergic neurons using human Parkinson’s disease postmortem brains and human microglia derived from induced pluripotent stem cells.